Ophthalmic Therapeutics Engineering Core

Project Summary – Ophthalmic Therapeutics Engineering Core
The Ophthalmic Therapeutics Engineering Core will provide essential resources to facilitate translational vision
science and technology research for development of new therapies for ocular diseases. The Core will support
instrumentation and technical expertise in molecular engineering required to characterize molecular nano-
assemblies designed to carry drugs coupled with expertise in device engineering for their targeted delivery or
direct therapeutic applications. The availability of shared and centralized resources accelerates the
development of new therapeutic approaches to efficiently and effectively deliver therapies precisely to specific
sites in the eye, using innovative technologies. The integrated resources of the Core will play an essential role
in bridging basic science, engineering, and translational vision research for developing novel ocular therapeutic
approaches. The specific aims are to provide instrumentation and technical expertise for: 1) developing,
characterizing and optimizing biological, chemical, or mechanical drug delivery systems; 2) designing and
fabricating custom devices and instruments that can improve or advance experimental procedures and
research capabilities of investigators, particularly those involving delivery of therapeutics; 3) training
investigators on the utility and operation of available instrumentation for the design and characterization of
therapeutic drug delivery vehicles and devices; and 4) consultations on the experimental design,
appropriateness of the specific techniques, and integration of engineering techniques to escalate the progress
of vision research projects.